ISGylation regulates lung endothelial inflammation

Abstract
Excessive lung microvascular endothelial inflammation is a pathological hallmark of acute
respiratory distress syndrome (ARDS). Upon inflammatory stimuli, lung endothelial cells (ECs)
increase chemokine and adhesion molecule expression, such as IL-6, and intercellular adhesion
molecule 1, ultimately causing neutrophil accumulation at the site of inflammation, endothelial
barrier dysfunction, and lung tissue damage in acute lung injury and sepsis. Nuclear
transcriptional factor κB (NF-κB) plays a pivotal role in EC inflammation. Inflammatory stimuli
trigger phosphorylation of NF-κB component p65, leading to increase p65 transcriptional activity.
We revealed that NF-κBp65 can be ISGylated. The ISGylated p65 is inactive in the resting ECs.
We also discovered that SCFFBXL19 E3 ligase catalyzes ISGylation of p65, impedes p65
phosphorylation, and mitigates lung EC inflammation. These observations led us to hypothesize
that p65 ISGylation by SCFFBXL19 dampens its phosphorylation, transcriptional activation, and lung
EC inflammation; and increases in FBXL19 stability mitigates lung EC inflammation through
reducing NF-kB activation. To better understand the new modification of p65, in this proposal, we
will determine molecular mechanisms by which SCFFBXL19 catalyzes p65 ISGylation and its role in
human lung microvascular EC inflammation. And then, we will determine the molecular
mechanisms by which p65 ISGylation impedes its phosphorylation and activation in human lung
microvascular ECs. Lastly, we will determine if stabilization of FBXL19 alleviates lung EC
inflammation in murine models of acute lung injury and sepsis. This application will be the first to
characterize SCFFBXL19-mediated ISGylation of NF-κBp65 and determine its role in the regulation
of p65 phosphorylation, transcriptional activation, and lung EC inflammation in acute lung injury
and sepsis.

Public health relevance
Lung microvascular endothelial dysfunction is a hallmark of acute lung injury and sepsis. The proposed studies will be the first to elucidate a new post-translational modification of NF-ĸBp65, ISGylation, and its inhibitory role in of NF-ĸB activation and lung endothelial inflammation. These studies will be critical in development of novel therapeutics by stabilization of ISG15 E3 ligase to diminish lung microvascular endothelial dysfunction in acute lung injury and sepsis.